Understanding and Engaging Families in HIV Biomedical Prevention for Latino Men Who Have Sex with Men

Project Summary/Abstract
Candidate: This K01 is submitted by Dr. del Pino, Associate Professor, from Charles R. Drew University of
Medicine and Science (CDU). This proposal is the next step in his transition from philosophy to public health
research. He seeks to reduce HIV disparities among Latino men who have sex with men (MSM) by analyzing
family support data from three prospective cohort studies in Los Angeles and Chicago and by conducting
formative research to leverage the siblings of Latino MSM in an HIV biomedical prevention intervention. He has
published qualitative and quantitative papers on family support, substance use, and HIV. He is currently
supported by the CDU Emerging Scholars Award and CRECD.
Career Development and Training Plan: Dr. del Pino's mentoring team includes Dr. Steve Shoptaw (expert
in substance use and biomedical interventions), Dr. Nina Harawa (expert in the development of culturally
responsive HIV-prevention interventions for MSM of color), and Dr. Arun Karlamangla (expert in complex
biostatistical data analysis and longitudinal clinical epidemiology research). The training goals (advanced
biostatistics, families and stigma, and intervention development) will be achieved through coursework and
individual tutorials with each mentor. He will have access to the UCLA CTSI (NCATS); UCLA CHIPTS (NIMH);
and to AXIS, CDU's center for clinical and translational research resources and trainings (NIMHD).
Research Plan: Despite the prevention and treatment efforts of the past 30 years, Latino MSM continue to be
disproportionately impacted by HIV. Yet a powerful cultural source of motivation has been underutilized: the
family. This project seeks to address HIV disparities by addressing gaps in our knowledge of (a) how family
support affects the behaviors and health of Latino MSM over time and (b) how to engage siblings in the
development and delivery of PrEP-use messages.
Aim 1: Determine how family support and mental health affect the HIV-related behaviors (e.g., substance use,
sexual risk) and HIV-related health (e.g., STI, HIV viral load) of Latino MSM over time. Hypothesis: Latino MSM
with greater family support over time will report better HIV-related risk behaviors and health outcomes than
Latino MSM who report little to no family support. Aim 2: Identify barriers and facilitators to engaging Latino
MSM and siblings in HIV biomedical interventions. Aim 3: Develop and pilot test sibling-delivered messages to
increase PrEP use in high-risk Latino MSM to gather feasibility and acceptability data and to refine the
intervention processes and messages.
Summary: The Career Development and Training Plan and the Research Plan will prepare Dr. del Pino to
submit an R01 to test the efficacy and effectiveness of a culturally-specific, sibling-based intervention to reduce
HIV disparities among Latino MSM. His mentorship team has the required expertise and established record of
mentoring junior researchers to ensure that he becomes an independently-funded investigator.

Public health relevance
PROJECT NARRATIVE /RELEVANCE TO PUBLIC HEALTH Despite the prevention and treatment efforts of the past 30 years, Latino men who have sex with men (MSM) continue to be disproportionately impacted by HIV nationally, and is particularly a problem in Los Angeles, which is a predominantly Latino minority city. Yet a powerful cultural source of motivation for behavior change has been underutilized: the family. The long-term goal of this K01 is for Dr. del Pino to become an independent investigator and national thought leader (1) to expand our understanding of the impact of family relationships on Latino MSM and how to include them in the development and testing of HIV biomedical interventions and (2) to address HIV and other health disparities in diverse sexual and gender minority communities.